Forebrain electroneutral transporters in salt-sensitive hypertension

PROJECT SUMMARY/ABSTRACT
Excess dietary salt intake is associated with cardiovascular disease and is a major contributing factor to the
pathogenesis of hypertension. Salt-sensitive hypertension in both humans and rodent models is associated with
elevations in plasma or cerebrospinal fluid [NaCl]. The resultant relative hypernatremia activates central circuits
to increase sympathetic nerve activity (SNA) and arterial blood pressure (ABP). There are brain NaCl-sensors
in the circumventricular organs such as the organum vasculosum of the lamina terminalis (OVLT) and
subfornical organ (SFO); activation of OVLT/SFO neurons stimulates thirst, vasopressin (AVP) secretion, and
SNA, whereas interruption of neurotransmission in OVLT/SFO lowers ABP in salt-sensitive models. However,
the mechanisms by which OVLT/SFO neurons sense extracellular [NaCl] are not known. Recent data suggest
the Na+-K+-2Cl- co-transporter (NKCC2) is not kidney specific but is also expressed in brain regions that regulate
whole body NaCl and water homeostasis. The central hypothesis of this proposal is that the ingestion of excess
dietary salt elevates extracellular [NaCl] to activate NaCl-sensitive neurons in the OVLT/SFO through NKCC2.
In turn, this activates descending pathways to elevate SNA and ABP. Furthermore, we hypothesize that these
NaCl-sensing mechanisms are sensitized in salt-sensitive humans, since our preliminary data show
hypernatremia evokes a greater increase in OVLT discharge of Dahl-salt sensitive versus Dahl-salt resistant rats
fed a high salt diet. We propose 2 specific aims. Specific Aim 1 will determine the extent by which NKCC2
mediates NaCl-sensing in OVLT/SFO neurons and elevate SNA and ABP to acute NaCl loading or chronic salt-
sensitive hypertension in rodents. Specific Aim 2 will test the hypothesis that an NKCC2 antagonist will blunt
hypernatremia-induced central neural activation and SNA in salt resistant and salt sensitive adults with high BP,
and that central neural activation will be greater in salt sensitive adults, suggesting heightened sodium sensing.
Successful completion of these aims will provide needed information on the cellular elements that mediate
intrinsic NaCl-sensing of hypothalamic neurons and provide novel data on central sodium sensing in salt
sensitive humans. This is a translational R01, bringing two laboratories together that have a track record of
successful collaboration, and these studies will provide a framework for the development of novel therapeutic
treatments of salt-sensitive hypertension.

Public health relevance
PROJECT NARRATIVE The ability of the brain to sense changing sodium levels in the blood is critical in mediating the neurohumoral responses to hypernatremia; however, the molecular mechanisms underlying sodium sensing are poorly understood. The purpose of this translational project is to identify key sodium-sensing regions of the brain and determine if the Na-K-2Cl co-transporter mediates the neurohumoral response to acute hypernatremia. Completion of this project will increase our understanding of blood pressure regulation and salt sensitive hypertension, which has public health implications.